IRAKM and MINCLE in ALD

ABSTRACT
A pivotal stage of the ALD progression is the development of hepatic inflammation, which substantially increases
the risk for fibrosis, cirrhosis and cancer. Despite the recent surge in the use of immunomodulatory biologics for
other inflammatory diseases, corticosteroids remain the only therapeutic for hepatic inflammation, underscoring
a major unmet clinical need. While evidence indicates that a combination of ethanol-induced hepatocyte cell
death and elevated circulating endotoxin drives hepatic inflammation in ALD, a major question arising is how the
chronic low grade inflammation is initiated and amplified in the progression of ALD. We reported that low-dose
endotoxin induces the expression of Mincle, a member of the C-type lectin receptor family that acts as a sensor
for cell death, via the IRAKM-dependent TLR4 signaling in hepatic macrophages. Mincle detects components
released by dead hepatocytes and activates inflammasomes and IL-1β production, serving as a critical link
between cell death and inflammation in murine models of ALD. Recently, we found serum concentrations of β-
glucosylceramide (GluCer), a Mincle ligand released by dying hepatocytes, are increased by ethanol feeding in
mice and highly elevated in sera from patients with AH. GluCer concentrations were positively correlated with
disease severity in patients, suggesting that GluCer may be a major Mincle ligand driving hepatic inflammation
and fibrosis in ALD. Intriguingly, Mincle activation leads to a non-lytic form of IL-1β secretion from hepatic
macrophages and hepatic stellate cells (HSCs) via a novel GSDMD-mediated biogenesis and release of small
extracellular vesicles (sEVs). The non-lytic IL-1β secretion spares hepatic macrophages from pyroptosis,
allowing them to continue amplifying the inflammatory response. Importantly, our preliminary data highlight a
critical pathogenic role for IL-1β containing sEVs in potentiating ethanol-induced liver injury in mice.
Mechanistically, we found that IL-1β induced the expression of SAA in hepatocytes, which in turn activated
caspase3-GSDME-mediated pyroptosis. Hepatocyte pyroptosis releases the danger signal HMGB1, which can
further activate caspase 1 and 11-dependent GSDMD-cleavage in neighboring hepatocytes, amplifying
hepatocyte injury. This escalation of injury not only impairs liver function but likely leads to further release of
GluCer, amplifying macrophage inflammatory responses. Importantly, our preliminary data reveal that GluCer
also activated HSCs, enhancing collagen deposition and aggravating liver fibrosis. By dissecting the GluCer-
Mincle-GSDMD-IL-1β-sEV cascade, this application will evaluate strategies and identify therapeutic targets to
interrupt this positive feed forward loop that amplifies the early stage hepatocyte cell death into debilitating
hepatic inflammation and fibrosis.

Public health relevance
PROJECT NARRATIVE Alcohol abuse is a leading cause of morbidity and mortality worldwide and recent data indicate that alcohol- associated liver disease (ALD) affects over 10 million Americans. The overall objective of this proposal is to investigate how innate immune responses, in combination with alcohol-induced hepatocellular injury, coordinately lead to the pathogenesis of ALD. Understanding the complex interaction between alcohol-induced hepatocellular injury and inflammatory and fibrotic responses will provide the foundation for the future development of rationally designed therapeutic interventions to slow and/or reverse ALD.